2021 ORS/PSRS 6th International Spine Research Symposium

The Philadelphia Spine Research Society (PSRS) has been conducting annual research meetings since 2004 and
the 2021 conference postponed to November 2022 due to the Covid-19 pandemic will be the 6th international
meeting of the Society in collaboration with the Orthopaedic Research Society (ORS). This proposal seeks
support to promote and enhance trainee and junior faculty attendance at the 2021 ORS PSRS 6th International
Spine Research Symposium. The Symposium will take place on November 6-10, 2019 at Skytop Lodge, Skytop,
PA which is a convenient location for both the greater New York and Philadelphia regions. The primary purpose
of this conference is to promote state-of-the-art research and to enhance scientific discourse and collaborations
in the broad field of intervertebral disc biology. Previous ORS-PSRS conferences have had an excellent track
record of bringing together researchers and clinicians from numerous disciplines at various stages of their
careers. Key features of the meeting include plenary lectures, state-of-the-art peer-reviewed presentations,
roundtable discussions, and trainee and student presentations. Hallmark features of this conference are its
relaxed atmosphere and purposefully unscheduled time to permit informal interactions and exchange of ideas
among participants. The main topics to be highlighted at the 2021 conference include molecular, cell, and
developmental biology of the disc, mechanisms of pathogenesis of disc degeneration, the molecular basis of
discogenic pain, biomechanics of the spine, functional tissue engineering, biomedical device design, and
rehabilitation. The conference organizers expect broad participation from basic researchers as well as clinicians
concerned with the diagnosis and treatment of spinal disorders including disc degeneration and back pain.

Public health relevance
NARRATIVE The Orthopaedic Research Society (ORS) and Philadelphia Spine Research Society (PSRS) are collaborating to hold the 2021 ORS PSRS 6th International Spine Research Symposium on November 6-10, 2022 at Skytop Lodge, Skytop, Pennsylvania. This conference will disseminate state-of-the-art research, enhance scientific discourse and promote collaborations in the field of intervertebral disc biology and biomechanics as it relates to spine health, aging, and degeneration. We will convene a diverse group of spine experts of varying expertise and career stage to promote the advancement of basic, translational and clinical science as it relates to intervertebral disc aging and disease, and their relationships to back pain.